Aging, alcohol, and microglia dysfunction

Abstract
The global population is aging rapidly, with an estimated 2.1 billion people aged 60 or over expected by 2050.
Aging baby boomers are contributing to an increase in heavy alcohol consumption and alcohol use disorders
(AUDs). Indeed, AUD rates have increased by 82.5% in those aged 65 and over, which exacerbates risk for
cognitive decline, accelerated aging, dementia, and early death. Excessive alcohol intake in aged individuals
likely dysregulates immune dynamics in brain. The neuroimmune system critically regulates cognitive and
behavioral changes with aging – pathological inflammatory priming and/or reactivity occurs with
neurodegenerative disorders and elicits cognitive decline. The main resident immune cell of the CNS, microglia,
help maintain a healthy milieu by surveying for damage or infection; by responding to damage-related cues; and
by phagocytosing dying cells and excess synapses. Microglia play key roles in alcohol-induced
neuroinflammation and in aging-related neurotoxicity; however, little is known about how alcohol and aging
intersect at the level of the neuroimmune system. Thus, here we propose that neuroinflammatory responses are
dysregulated in the aged brain resulting in increased vulnerability to the neuropathological effects of heavy,
alcohol exposure. We provide strong preliminary data demonstrating that heavy binge-like exposure to alcohol
leads to substantial and progressive impairments in cognition and an altered neuroimmune environment. Our
overall objective is to determine whether dysregulated neuroimmune, and particularly microglia, function is
critical to this heightened age-associated damage following heavy, alcohol exposure. The central hypothesis of
this proposal is that heavy alcohol exposure in aging produces delayed hippocampal neurodegeneration and
cognitive deficits through impaired microglia phagocytic and inflammatory functions. The proposal addresses the
following specific aims: First, characterize the interaction of aging and heavy, binge-like alcohol exposure on
corticolimbic structure and function. Second, determine how aging and alcohol interact to induce changes in
microglia phenotype and function following heavy, alcohol exposure. Third, interrogate the role of microglia
dysfunction following alcohol in aged rats on corticolimbic structure and function. The third mechanism-focused
aim will examine the precise role of microglia in contributing to damage in the aged brain in response to alcohol.
The proposal is innovative in combining expertise in alcohol use disorders, aging, and neuroimmunology. It uses
state-of-the-art approaches including ex vivo microglia functional assays, confocal microscopy and 3D cellular
reconstructions, microglia depletion, and single cell RNA-sequencing to identify novel pathways perturbed by
alcohol exposure in the aging system. This contribution will be significant as alcohol use is a growing concern in
aged populations but an understudied area. The proposed studies will provide a mechanistic foundation to
elucidate novel targets for therapeutic intervention to reduce alcohol-induced brain and cognitive/behavioral
impairments and explore alcohol's acceleration of brain aging.

Public health relevance
Project Narrative An aging population coupled with a significant increase in propensity for alcohol consumption is a critical public health concern: alcohol use disorder increased by 82.5% in those aged 65 and over, exacerbating risk for other health issues such as cognitive decline, accelerated aging, and dementia. Neuroimmune processes are implicated in both natural aging as well as alcohol-induced brain damage. Here we will determine the neuroimmune mechanisms through which acute heavy alcohol exposure in aged animals exacerbates central nervous system damage with a focus on microglia dysfunction, in order to elucidate novel targets for mitigating alcohol-accelerated brain aging.